Creating adaptive, wearable technologies to assess and intervene for individuals with ADRDs

PROJECT SUMMARY / ABSTRACT
Advances in machine learning and low-cost, wearable sensors offer a practical method for understanding,
assessing, and intervening for Alzheimer's Disease and Related Dementias (ADRDs) in everyday spaces. We
propose to create a Behaviorome research program that will create ground-breaking methods for building
health-predictive models from wearable sensor data by mapping patterns of behavior using machine learning
and pervasive computing technologies. This program will create innovative multidisciplinary ideas to address
NIH ADRD Milestone 11.c, Embed wearable technologies/pervasive computing in existing and new clinical
research. Our research program builds on a history of interdisciplinary research contributions in areas
including human behavior modeling from longitudinal sensor data and design of novel assessment and
intervention mechanisms. We propose to design and validate methods for mapping a human behaviorome “in
the wild”, automatically assessing cognitive and functional health from behavior markers, scaling technologies
through machine learning, linking health and behavior with their influences, and closing the loop with
automated interventions. Similarly, our mentoring program builds on experience training students and early-
career investigators to become leaders in the field of gerontechnology. We will recruit and train graduate
students and early-stage researchers, including those from underrepresented groups, to grow an institutional
multidisciplinary Behaviorome research program and to establish new research programs that contribute to
the targeted Milestone. We will scale the impact of mentoring by establishing a webinar series and creating
youtube videos that highlight and explain breakthroughs in the design and application of Behaviorome
research. Results of this program will include scripts and templates to construct a behaviorome with resource-
limited wearable devices, scale data and models to large diverse populations, integrate data with multiple
information sources (e.g., genetics), automate health assessment and intervention, and create understandable
explanations of data and models. These will contribute to existing clinical studies such as the clinician-in-the-
loop smart home, digital memory notebook, and pervasive computing measures of functional performance.
Furthermore, they will lead to new clinical studies that formalize connections between health and its
influences, exploration of the impact of ethnicity and the built environment on health, and the design of ADRD
interventions for medication adherence, task prompting, and negative interaction de-escalation. The proposed
contributions are significant because they will provide insights on detecting and assessing ADRDs within a
person's everyday environment using wearable sensing and pervasive computing methods that have not been
investigated in prior work. Additionally, the mentoring steps will pave the way for a new generation of
researchers to offer improved methods of addressing the need to understand, assess, and intervene for ADRDs
in everyday settings, thereby improving quality of life and reducing health care costs.

Public health relevance
PROJECT NARRATIVE We propose to build a multidisciplinary research and mentoring program that will design wearable sensing and pervasive computing technologies to improve detection, assessment and intervention for individuals with Alzheimer's disease and related dementias (ADRDs). Built on a foundation of existing research and mentoring collaboration between computer science and neuropsychology, we will design and validate methods to analyze the relationship between ADRDs and behavior. We will create robust health-predictive models from longitudinal sensor data collected in naturalistic settings and will connect health and behavior with multiple influences, such as genetics and environment, to advance quality of care and reduce functional disability associated with ADRDs.